Outcome measures and quantitative EEG biomarkers in SYNGAP1-related disorders

PROJECT SUMMARY
The proposed research aims to advance clinical trial readiness for SYNGAP1-related disorder
(SYNGAP1-RD), a rare monogenic epilepsy associated with severe neurodevelopmental differences
including epilepsy, intellectual disability, and autism spectrum disorder. Currently, the absence of natural
history data and validated outcome measures hinders the assessment of therapeutic efficacy in clinical
trials for SYNGAP1-RD and similar rare genetic epilepsies. This project will bridge this gap by defining
disease trajectories and establishing reliable clinical and biomarker-based outcome measures. This
study builds on preliminary work to determine disease trajectories, identify developmental and seizure
patterns, and explore quantitative EEG (qEEG) features as biomarkers in SYNGAP1-RD. The
objectives of the current study will be addressed through two specific aims. In Aim #1, I will follow a
cohort of 50 individuals aged 2-10 years with SYNGAP1-RD prospectively to characterize
developmental progress and seizure patterns. Regular assessments using tools like the Bayley-4 and
Peabody will track motor and cognitive domains to distinguish predictable disease courses from
treatment effects in potential future trials. In Aim #2 of this project, I will examine qEEG features as
potential biomarkers for SYNGAP1-RD, focusing on specific findings such as the occipital alpha/theta
power ratio, which I previously identified to be distinct in SYNGAP1-RD from controls and other genetic
epilepsies. qEEG assessments in the study cohort, with comparison against age-matched controls, will
clarify whether these features correlate with clinical severity and can predict developmental outcomes,
ultimately identifying qEEG-based markers suitable for clinical trials. In addition, I will explore novel
qEEG features, using random forest models to select key features to identify novel qEEG markers
correlated with SYNGAP1 severity. As an expected outcome, this NIH K23 career development award
will support my training in longitudinal study design, outcome measure validation, and advanced qEEG
analysis. These efforts aim to provide a foundation for future precision therapies and ensure my
progression toward an independent R01-funded career in rare neurological diseases, focusing on tools
to evaluate and implement treatments effectively. The anticipated results will address critical gaps in
clinical trial readiness, with validated outcome measures and biomarkers that may serve as robust
endpoints in SYNGAP1-RD and potentially in other genetic epilepsies.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health as rare genetic epilepsies, when taken together, present a significant burden to human disease. Precision medicine therapies are currently under development for many of these conditions, but most lack the detailed natural history data, well-defined outcome measures, and biomarkers necessary for clinical trial readiness. This research is relevant to the purpose of the NIH K23 Award and mission of the NINDS by providing a tailored program to enhance the applicant’s skills in prospective clinical assessments, digital health tools tracking seizure outcomes, and quantitative EEG in a large cohort of individuals with SYNGAP1-related disorders in order to use this knowledge to reduce the burden of neurological disease.